Estimating Life Course Patterns and Years of Life Lived Taking Prescription Drugs

PROJECT SUMMARY
Prescription drug use has reached historic highs in the United States, with nearly half of all Americans
and over 80% of the population aged 60 and older reporting taking prescription drugs in the past 30 days in
2015-2016. Prescription drugs have become a mainstay of medical treatment for an ever expanding array of
conditions. Not only are more Americans taking drugs, but they are taking more of them concurrently
(polypharmacy) and for longer durations. While prescription drugs have contributed to improvements in health
and mortality, these trends in prescription drug use have also prompted concerns related to overprescribing,
rising health care costs, adverse drug events, and quality of life impacts. These issues are particularly salient
for older adults, who are the largest per capita consumers of prescription drugs. Increasing attention is being
paid to the consequences of prescription drug use, particularly in light of the contemporary American opioid
epidemic, which was initially driven by the overuse of prescription opioid painkillers. However, there are no
existing measures of life course patterns of prescription drug use, including how much of their lives Americans
can now expect to spend taking prescription drugs or ages at initiation of sustained prescription drug use. This
project will produce those measures leveraging data from the Medical Expenditure Panel Survey (MEPS), a
long running, nationally representative survey that collects high quality data on prescription drug use,
combined with life tables from the Human Mortality Database (HMD). We will estimate period life tables for
prescription drug use using a novel application of Sullivan's method, which is used to estimate health
expectancies. We will estimate the number of years Americans can expect to spend taking (and not taking): (1)
any prescription drugs; (2) specific types of prescription drugs (i.e., therapeutic drug classes); and (3) numbers
of prescription drugs (0, 1, 2, 3, 4, 5+) to capture polypharmacy by age and sex for each year between 1996
and 2017. We are also interested in changing patterns of prescription drug use across birth cohorts. The
majority of drugs used to treat chronic disease were developed after 1950; thus, older adults today, unlike their
predecessors, are the first birth cohorts of older adults to have experienced decades of sustained prescription
drug use over the life course. We implement a methodological innovation that uses Sullivan's method to
calculate temporary life expectancy (i.e., the years of life lived spent taking prescription drugs within a specific
age range) for birth cohorts. This innovation, which can be extended to many other research questions using
multistate methods for cohorts, will allow us to produce similar estimates to those described above of the
number of years birth cohorts born between 1927 and 1996 have spent taking any prescription drugs, specific
classes of drugs, and specific numbers of prescription drugs. These estimates have important implications for
contemporary debates surrounding prescription drug use including overprescribing, spending, polypharmacy,
and the risk of experiencing adverse drug events.

Public health relevance
PROJECT NARRATIVE Prescription drug use has reached historic highs in the United States, with Americans increasingly taking multiple prescription drugs concurrently and for longer durations – often from the initial development of a chronic disease and lasting for the remainder of their lifetimes. This project will produce the first estimates of life course patterns of prescription drug use, allowing us to identify how much of people's lives are spent taking prescription drugs (including specific classes of drugs and the number of drugs being taken), at which ages sustained prescription drug use begins, and how these measures have changed over time and across birth cohorts. The results have important implications for health and well-being, health care costs, overprescribing, polypharmacy, and adverse drug events.